2022 Control of Renal Function in Health & Disease: New Frontiers

2022 Control of Renal Function in Health and Disease: New Frontiers
Project Summary/Abstract
This NIH R13 grant application seek support for a travel award program for the upcoming 2022 conference
entitled “Control of Renal Function in Health and Disease: New Frontiers”. The American Physiological Society
and the American Society of Nephrology are sponsoring the conference which is scheduled for June 26-30, 2022
in Charlottesville, Virginia. There are several major translational and therapeutic areas included in the meeting
that have relevance to the scientific community. Nearly 30% of the U.S. population has hypertension and only
50% of individuals with hypertension have their blood pressure controlled. Human and animal studies have
shown that hypertension changes the kidney’s ability to regulate salt and water homeostasis, both affected by
renal hemodynamic and inflammation-mediated mechanisms. Thus, the kidney plays a key role in the
pathogenesis of hypertension and is a major target of end-organ-damage that further exacerbates hypertension.
In addition, the growing epidemic of obesity, metabolic syndrome and diabetes has led to a large increase in the
incidence of chronic kidney disease (CKD). Finally, acute kidney injury (AKI) is also on the rise as a result of
increasing ischemic and nephrotoxic events. We must gain a better understanding as to how renal injury occurs
as a result of hypertension, CKD, and AKI. In the last 5 years, there have been several novel methodologies
developed to study kidney function and disease that would be of interest to renal physiologists and nephrologists
alike. Thus, there is a great need in the scientific community for a conference focused on these topics. The
organizing committee has developed a meeting program that focuses on novel areas of kidney function and
disease including symposia on the following topics: obesity, diabetes and metabolic syndrome; inflammation and
the kidney; developmental programming of kidney disease; genetics, epigenetics of the kidney; immunology and
the kidney, circadian biology of kidney function, single cell RNASEQ in kidney disease and organoids. Symposia
will also cover recent advances in traditional areas of renal hemodynamics, acute kidney injury, integrative
control of kidney function, chronic kidney disease, autacoids and nutrition in kidney function and hypertension.
In order to promote the interest of trainees and early career investigators in the field and their participation in the
conference, we propose to administer an NIH-funded travel award program for trainees and early career
investigators.

Public health relevance
2022 Control of Renal Function in Health and Disease: New Frontiers Project Narrative The purpose of the 2022 Control of Renal Function in Health and Disease conference is to gather a critical mass of diverse and expert basic, clinical and translational researchers with interests in the mechanisms underlying kidney and cardiovascular disease and renal hemodynamics to encourage the exchange of ideas, develop scientific relationships, and promote potential collaborations in the future through the presentation of late breaking research. Additionally, the conference will promote the interest of junior investigators and trainees in developing new studies into the roles of inflammation, hypertension, genomics and genetics of kidney disease.